THE INVESTIGATION AND TREATMENT OF PATIENTS WITH NON-HODGKIN'S LYMPHOMA

Ninety-nine patients have now been admitted to the primary protocol for the treatment of non-Hodgkin's lymphoma, and the goals of this protocol, namely, to define different prognostic groups within this broad category of patients have largely been achieved. Utilizing a CHOP - high dose methotrexate regimen, the results in lymphoblastic lymphoma without marrow involvement and patients with entirely resected intraabdominal undifferentiated lymphoma or localized disease have been excellent (currently 82% and 90% disease-free suvival). Among the remaining patients the most important prognostic features are soluble interleukin-II level and bone marrow involvement. Current focus is on high risk patients with undifferentiated lymphomas, defined as all patients other than those with localised disease (stage A) or completely resected disease (stage AR). These patients are being treated on an intensified version of 7704 while a new drug combination of ifosfamide, VP16 and high dose ara-C is evaluated in relapse patients. Because of the evident activity of the relapse protcol, we are beginning to plan a new primary prtocol incorporating the new drug combination.